Cooperative Catalysis Using Earth Abundant Metals

Project Summary
Homogeneous transition metal catalysis is one of the most significant tools in drug discovery and biomedical
research. The development of practical, environmentally friendly catalysts remains an important goal in medicinal
and process chemistry, as the sustainable development of new medicines is dependent on the availability of a
diverse set of synthetic methods. However, the pharmaceutical and chemical industry is over-reliant on precious
metal elements which are scarce, toxic and, expensive. This proposal describes research into novel metal
complexes based upon abundant 1st-row metalate species for application in catalytic transformations of
biologically relevant small molecules. In Aim 1 of the proposal, we will develop and investigate the structural and
electronic features of a new class of metal complexes in unusually low oxidation states and supported by N-
heterocyclic phosphenium ions (NHPs). This knowledge will then be used to facilitate the development of
functional catalysts. In Aim 2, the development of metalate-catalyzed transformations will be investigated. A
major focus will be on the development of small molecule functionalization using careful mechanistic analysis of
the novel pathways likely to emerge from the use of unprecedented metalate catalysts. The new catalysts and
transformations developed in this proposal will allow medicinal and process chemists the ability to conserve
valuable and non-sustainable resources (precious metals) which represent a key technology in drug
development. These approaches will in turn be useful in the preparation of new materials and medicines to
further biomedical research.

Public health relevance
PUBLIC HEALTH RELEVANCE STATEMENT (PROJECT NARRATIVE) The studies described in this research proposal will lead to a broader understanding of how to mimic the chemistry of metalloenzymes which use abundant 1st-row metal elements in catalysis. We are particularly interested in understanding the structure, spectroscopy, and reactivity of 1st-row metalates – transition metals in unusually low oxidation states. The use of synthetic inorganic complexes that mimics some features of the active centers of metalloenzymes will allow us to reduce our dependence on 2nd and 3rd-row metal elements which are known to pose toxicological risks to human health.